Mechanisms of Revertant Mosaicism in Ichthyosis with Confetti

PROJECT SUMMARY
Revertant mosaicism (RM) occurs from spontaneous, somatic correction of pathogenic mutation,
giving rise to areas of normal tissue. Ichthyosis with confetti (IWC), an autosomal dominant skin
disorder caused by mutations affecting the tail domains of keratin 10 (K10) and keratin 1 (K1), is
remarkable for its high frequency of RM, as patients develop hundreds to thousands of revertant
islands of normal skin beginning in childhood. Interestingly, each revertant clone arises from
independent copy-neutral loss-of-heterozygosity (CN-LOH), likely via homologous recombination
(HR) of the mutant haplotype. Furthermore, the revertant macules are observed to grow in size and
number over time, suggesting intercellular competition favoring the selection and expansion of
revertant clones over their mutant neighbors. We have successfully demonstrated that expression of
IWC mutant keratins uniquely increase the rate of HR, while inducing the formation of DNA double-
strand breaks (DSBs). Furthermore, we have developed a conditional knock-in model of IWC, which
clinically and histologically recapitulates disease including revertant mosaicism via CN-LOH, and
demonstrates expansion of revertant, wild type clones.
We now propose to systematically identify and interrogate the mechanisms and mediators governing
IWC keratin-induced HR and cellular competition. We will investigate which DNA damage response
(DDR) components are recruited to sites of keratin-induced DSBs, characterize the kinetics of DSB
formation and resolution, and pinpoint the stage in the cell cycle at which damage occurs. We
propose to utilize intravital live-imaging to explore, at the cellular level, whether altered rates of
mitosis, apoptosis, or differentiation/delamination underlie the intercellular competition in IWC. Finally,
we will perform single-cell RNA sequencing and CRISPR knockout screens, to identify mediators of
intercellular competition and determinants or modifiers of HR in IWC. We will further examine
compelling candidates in IWC patient and murine tissue and cells. Elucidating the previse
mechanisms of genetic reversion and intercellular competition in IWC has the potential to identify
pathways which may enable therapeutic recombination to treat inherited and acquired dominant
genetic disorders.

Public health relevance
PROJECT NARRATIVE Genetic self-correction is vanishingly rare in human disease, yet in the severe rare skin disorder ichthyosis with confetti (IWC), affected individuals develop hundreds to thousands of spots of self- corrected normal skin. We have found that mutations in KRT1 and KRT10 that cause IWC lead to DNA damage favoring self-correction via copy neutral loss of heterozygosity while also providing a selective advantage to corrected clones, permitting their expansion. Our experiments will identify the specific cellular pathways which are required for genetic self-correction and normal clone expansion; by identifying these pathways, it may become possible to develop tools to enhance self-correction not only in IWC, but also in any genetic disorder resulting from one copy of a mutant gene.